Characterization Of The Specialized Pro-Resolving Lipid Mediator Metabolome and Implications For Their Endogenous Formation

PROJECT SUMMARY
Out of control, or dysregulated, inflammation is a hallmark of numerous human diseases. Oxidized lipid
mediators, oxylipins, are short-lived autacoids that play important roles in the etiology of inflammation.
Quantification of urinary metabolites of prostaglandins and leukotrienes has been a key approach towards
understanding of the role of these molecules – as well as the drugs used to inhibit them (ie. aspirin) – in human
physiology and disease. Specialized pro-resolving lipid mediators (SPMs) are oxylipins typically generated from
eicosapentaenoic acid (EPA) and docosahexaenoic acid (DHA), that promote the resolution of inflammation.
SPMs and their stable analogues are being developed as therapeutics to treat inflammatory-related diseases.
But, while these molecules have been detected in certain biological settings, the extent to which SPMs are
generated in vivo remains unclear. Importantly, there are distinct biological mechanisms – such as SPM
metabolism and quantification of SPM metabolites – that have yet to be considered. Recently, our laboratory
identified a novel route of SPM metabolism. We demonstrated that resolvin D5 (RvD5), one of the most abundant
SPMs, is a substrate for uridine 5'-diphospho-glucuronosyltransferase (UGT) 1A9 and is rapidly metabolized via
glucuronide conjugation. Limited studies on SPM metabolism exist; thus, we seek herein to gain a
comprehensive understanding of SPM transformation. The central hypothesis of this proposal is that
understanding the metabolism of SPMs is critical for the accurate and complete quantification of these bioactive
lipids in human disease and homeostasis. We seek to address this hypothesis through three specific aims. In
Specific Aim 1, we will identify and characterize routes pathways by which SPM are transformed using an in vitro
model of human metabolism. We will study the metabolic inactivation of four structurally-distinct SPM – resolvin
E4 (RvE4), resolvin D1 (RvD1), RvD5, and maresin 2 (MaR2). In Specific Aim 2, we will follow the metabolism
of these SPMs in mouse models of human metabolism and inflammation. Additionally, we will utilize human
plasma and urine samples previously collected as part of the Fatty Acid Desaturase Activity, Fish Oil, and
Colorectal Cancer Prevention Study (FADAFO) to evaluate SPM metabolite formation in humans. Finally, in
Specific Aim 3, we will address the concept that metabolism of SPM, particularly by UGTs, can be affected by
commonly used medications, including non-steroidal anti-inflammatory drugs (NSAIDs). The effect of aspirin,
ibuprofen, and other NSAIDs on the metabolism of SPMs will be explored in our proposed cellular and animal
models. Together these aims present an innovative approach to detecting endogenous SPM formation.
Identifying pathways that transform these molecules and establishing precise methods to ensure their accurate
quantification will help to clarify mechanisms – and therapies – that regulate inflammation and outline a unique
strategy to comprehensively evaluate SPM production for human clinical trials and epidemiological studies.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance) Out of control, or dysregulated, inflammation is a hallmark of numerous human diseases, including periodontitis, atherosclerosis, rheumatoid arthritis, and long COVID. We propose to study how certain oxidized lipids that promote the resolution of inflammation are broken down in the body. Identifying pathways that transform these molecules and establishing precise methods to ensure their accurate quantification will help to clarify mechanisms – and potential therapies – that regulate inflammation.